Immune cell contributions to inflammatory arthritis

Psoriatic arthritis (PsA) is characterized by dactylitis, enthesitis, synovitis, and bone erosions, leading to
significant morbidity and disability. Current treatment strategies targeting inhibition of TNF, IL-23, IL-17A, JAKs,
or PDE4 inhibitors slow down but do not prevent, PsA pathogenesis. Similarly, treatment with the T cell targeted
therapy cyclosporine has limited efficacy on PsA symptoms and progression. These findings suggest that other
cell types or inflammatory proteins contribute to PsA pathogenesis. B cells are present in PsA patient synovial
fluid and colocalize with T cells in PsA synovial tissue, consistent with ectopic lymphoid neogenesis. In this
immune cell-dense region, B, T, and antigen-presenting cells interact to modulate and drive inflammation. PsA
patients treated with rituximab, a B cell inhibitor, have improved arthritis clinical outcomes. Despite these
observations, it remains unclear how B cells contribute to the pathogenesis of PsA.
We recently engineered a mouse model of PsA (called Klk6+) that spontaneously develops a phenotype
modelling human PsA, including dactylitis, enthesitis, synovitis, and radiographic erosive changes to the axial
and appendicular skeletons. Klk6+ mice have decreases in anti-inflammatory IL-10+ Breg cells and increases in
proinflammatory IL-6+ Beff cells that occur concomitant with increases in Th1 and Th17 cells, paralleling findings
reported in PsA patients. Thus, the Klk6+ PsA mouse model represents a highly relevant model for studying B
cell contributions to inflammatory arthritis and uniquely positions us to delineate the mechanisms by which this
occurs. Using Klk6+ animals and samples obtained from PsA patients, we will test the conceptually innovative
hypothesis that decreases in anti-inflammatory IL-10-producing Bregs and increases in proinflammatory IL-6-
producing Beff cells promote Th17 cell inflammation and PsA development. Using a combination of innovative
mouse molecular genetics approaches, cutting-edge single-cell sequencing and spatial transcriptomics, CyTOF,
flow cytometry, and careful examination of improvement in individual PsA domains in mice, we will: 1.
demonstrate that the PsA phenotype observed in Klk6+ mice is mediated by proinflammatory IL-6-producing Beff
cell populations that promote Th17 and Th1 T cell inflammation and loss of the anti-inflammatory IL-10-producing
Breg population; 2. elucidate the cellular and molecular mechanisms by which this occurs and 3. translate these
findings to PsA patients.
Collectively, our studies will identify B cells as new pathogenic contributors to PsA etiology and will identify
the cellular mechanisms mediating B cell-T cell interactions that promote inflammatory arthritis. Our ability to
translate and confirm our findings in PsA patients may lead to a paradigm shift in understanding PsA
pathogenesis and the repurposing of existing FDA-approved drugs for treating PsA.

Public health relevance
Psoriatic arthritis is a debilitating yet poorly understood joint disease that affects ~1 million Americans. Using a newly engineered mouse model of psoriatic arthritis, joint tissues from psoriasis patients, and cutting-edge transcriptomics technologies, we will determine whether B cells, a class of immune cells long overlooked in the psoriasis field, are essential drivers of psoriatic arthritis. The results of this research will bring clarity to the longstanding questions of how psoriatic arthritis arises, why it does not respond to many of our current therapies for psoriasis of the skin, and what existing FDA-approved agents may be repurposed to treat this devastating disease.